Core C Uganda

PROJECT SUMMARY– RUSTBELT CFAR UGANDA CORE C Revision Overall
RUSTBELT CFAR Uganda Core C is a state-of-the-art laboratory with cutting-edge technology that meets the
demands of modern-day HIV research into cures, pathogenesis, co-morbidities, and co-infections. The Core is
central to the research collaboration between Makerere University (MU), located in Kampala Uganda, the
RUSTBELT CFAR and its partner hospitals and institutions. Through the "Microbiology and Immunology
Training for HIV and HIV-Related Research in Uganda” (MITHU, D43 TW010319, PI: Boom), we have
established a robust pipeline of Ugandan Ph.D. students at CWRU. Historically, our Ph.D. graduates have moved
on to become faculty members at MU or have research positions at JCRC. Unfortunately, many of our
outstanding students have uncertain futures because of a lack of resources in Uganda. To address this
challenge, the “RUSTBELT CFAR Ugandan Faculty Development Program” will engage the infrastructure and
outstanding laboratory facilities available through the RUSTBELT CFAR to support and mentor Ugandan
investigators returning to the country. We have modeled this effort on the NIH “Path to Independence” awards
but include enhanced mentorship and travel to tailor the program to conditions in Uganda. We will also support
Clinical Fellows entering HIV clinical research. Each “RUSTBELT CFAR Ugandan Faculty Development
Program” participant will have joint Ugandan and CFAR mentors. The mentoring relationship will be specified
in a written mentoring agreement that clearly defines the responsibilities of each party. Typically, there will be
focused monthly meetings with the primary mentors and semi-annual meetings with the Steering Committee to
monitor progress. For translational investigators, topics will focus primarily on HIV cure, HIV drug resistance,
and HIV-associated co-morbidities. For clinical investigators, the focus is to gain expertise in designing and
conducting clinical trials by inclusion in the operations of the Case and Pitt Clinical Trials Units (CTU) and JCRC
Clinical Research Site (CRS), and International AIDS Clinical Trials Unit in Kampala (AI 069501, PIs
Jacobson (CWRU, Core D co-Director) Kityo (JCRC)). Support for faculty development in Uganda will not
simply be restricted to Core C activities in Uganda since the entire CFAR clinical and laboratory infrastructure
will be used to support technology transfer and promote research with our Ugandan colleagues. We have
included annual working visits to the US to promote technology transfer, advanced training, and expansion of
collaborative activities. By leveraging the resources available through the RUSTBELT CFAR, this unique initiative
will substantially ameliorate the chronic underrepresentation of translational and clinical researchers from low-
and middle-income countries and enhance the diversity of investigators focusing on HIV-focused clinical and
translational studies.